Impacts of Phosphofructokinase-2 on Cardiac Electrophysiology and Function in Diabetes

Cardiovascular disease is the leading cause of death in individuals with type 1 diabetes (T1D) and arrhythmia
serves as a prominent contributor to this mortality. Prolongation of the QT interval represents vulnerability to fatal
ventricular tachyarrhythmia and is strongly associated with T1D. However, the cause of QT prolongation in this
population is incompletely understood. A decrease in PFKFB2, the cardiac isoform of the critical glycolytic
regulator phosphofructokinase-2 (PFK-2), may contribute. Despite degradation of PFKFB2 in diabetes, little is
known regarding consequences of its loss on cardiac function and electrophysiology. A lack of suitable models
manipulating PFK-2-mediated glycolytic regulation using a cardiac-specific approach has limited investigation
into these relationships. However, we are now poised to address this using a novel cardiomyocyte-specific Pfkfb2
knockout mouse (cKO) as well as a model that overexpresses constitutively active PFK-2 in the heart (GlycoHi).
Interestingly, we have recently shown that cKO animals exhibit QT prolongation, dilation, and decreased cardiac
function. This occurs in concordance with activation of the hexosamine biosynthesis pathway (HBP), a metabolic
pathway which branches from glycolysis directly upstream of phosphofructokinase and drives pathologic
functional and electrophysiological remodeling in the diabetic heart. The overarching hypothesis of this proposal
is that glycolytic dysregulation due to loss of cardiac PFK-2 is responsible for impaired cardiac function and
arrhythmogenic predisposition observed in T1D. Aim 1 will investigate mechanistic underpinnings of the
relationship between glycolytic regulation in the heart and cardiac mechanical and electrical function. I will utilize
an AAV9-mediated knockdown of the rate-limiting HBP enzyme in cKO and wildtype mice and measure cardiac
functional and electrophysiological parameters. I will use collected hearts to assess posttranslational modification
of known HBP-targeted transcriptional and electrophysiological regulators. In further mechanistic studies utilizing
isolated cardiomyocytes, I will pharmacologically target the HBP and an immediate downstream effector. We will
then investigate impacts on ion channel expression, action potential duration, and relevant K+ currents. Aim 2
will determine whether upregulation of PFK-2 preserves metabolic substrate preference and rescues the
pathologic changes to electrical and mechanical function observed in T1D. Using a streptozotocin-induced T1D
stress in the GlycoHi model, I will interrogate mitochondrial respiration, metabolic enzyme abundance, glycolytic
flux, cardiac function, and electrophysiological parameters. These experiments will illuminate an unexplored
relationship between PFK-2, a critical glycolytic regulator, and electrocardiographic and functional changes
commonly observed in a disease marked by its degradation. Further, a protective effect of PFK-2 activity in T1D
would provide a new therapeutic direction for diabetic cardiomyopathy while advancing our understanding of
how glucose metabolism interacts with electrophysiology in the heart. Lastly, these studies will provide me with
key training opportunities in electrophysiology, echocardiography, biochemistry, and molecular physiology.

Public health relevance
PROJECT NARRATIVE Diabetes is a public health crisis that is increasing in prevalence worldwide, with cardiovascular disease the leading cause of associated death. Two significant contributors to this mortality are heart failure and arrhythmia. This work aims to elucidate mechanisms by which changes in glucose metabolism, which are central to diabetic pathology, impact cardiac function and electrophysiology.